Exposure to complement induced preeclampsia promotes fetal steatosis

Abstract:
Now it is well recognized that exposure to adverse intrauterine environment can greatly affect the
health postnatally and in adulthood. Exposure to maternal obesity during gestation is linked to
offspring adiposity, premature mortality from cardiovascular disease and hepatic steatosis in
humans. Evidence from different experimental animal models including rodents and non-human
primates strongly suggests that exposure to maternal overnutrition during gestation promotes fetal
hepatic fat storage (steatosis) with a long-lasting metabolic consequence for offspring.
In contrast to steatosis in adults where increased hepatic de novo lipogenesis and decreased fatty
acid oxidation are observed, steatosis in fetuses exposed to maternal obesity is predominantly
due to increased transplacental fuel transfer since increased de novo lipogenesis is not observed
in them. Increased hepatic de novo cholesterol synthesis and its decreased clearance were also
observed in adult NAFLD/NASH. Regardless of the source of lipids, obesity associated steatosis
in both prenatal and adults is characterized by overwhelming hepatic lipid load surpassing
hepatocyte lipid metabolic contingency.
In contrast to nutrition rich intrauterine environment of maternal obesity, PE is often associated
with reduced nutritional supply to the developing fetus and consequent intrauterine growth
restriction (IUGR). Prevalence of NAFLD is about 4 times higher in children after IUGR compared
to those with normal birth weight. Adulthood NAFLD is independent of childhood body mass index
and insulin secretion ruling out catch-up growth as the sole reason for NAFLD. The mechanism
linking IUGR to adulthood NAFLD is not known. Under normal physiological conditions two
important sources for liver lipids including cholesterol are de novo synthesis and receptor
mediated import from blood circulation. Since liver is not a lipid storage depot, liver lipids are
utilized in β-oxidation or secreted out mainly as very low-density lipoproteins (VLDL). Cholesterol
is an obligate component of VLDL and required for VLDL secretion from the liver. Based on these
observations we hypothesize that in IUGR fetuses steatosis occurs due to increased import of
lipids accompanied by the deficiency of cholesterol and impaired VLDL secretion. Fetal liver
steatosis could prime the liver for later liver metabolic diseases through similar mechanisms as
involved in maternal obesity associated adulthood NAFLD.
In this application we propose to understand fetal liver lipid metabolism under IUGR using a novel
PE mouse model we recently developed in our laboratory.

Public health relevance
Preeclampsia is a pregnancy specific hypertensive disorder affecting 3-10% of all pregnant women and is often associated with fetal growth restriction and adulthood non-alcoholic fatty liver disease. The mechanism linking IUGR to adulthood NAFLD is not known.